Chronic Monitoring for a Chronic Condition: Leveraging Digital Assessment to Determine Lifestyle Impacts on Cognitive Aging in Epilepsy

The proposed K23 will support Dr. Alena Stasenko’s goal of becoming a leading researcher in risk and resilience models of cognitive aging in epilepsy and developing novel, tech-based interventions to improve brain health. This proposal has significant

Public health relevance
Cognitive impairment and risk for accelerated cognitive aging in older adults with epilepsy is a major public health concern, yet we lack effective strategies for optimizing cognitive health in this vulnerable and fast-growing group. This proposal aims to determine the unique contribution of modifiable lifestyle factors such as physically, socially, and mentally stimulating activities to cognitive function in older adults with epilepsy using innovative digital health technology to longitudinally track outcomes. Understanding the impact of lifestyle behaviors on cognitive comorbidities and premature cognitive aging in epilepsy has implications for targeted interventions, clinical guidelines, and policy.